IL-36 activity during skin infections

SUMMARY
Interleukin-36 (IL-36) represents IL-36a, IL-36b and IL-36g, which are related to IL-1a and IL-1b. The IL-36
cytokines are increasingly being linked to inflammatory conditions due to elevated expression in affected
tissues; however, our understanding of how these cytokines are activated and inactivated remain limited. This
knowledge gap hinders informed decision making when starting clinical trials involving IL-36 receptor
neutralizing antibodies and the development of cheaper small molecule drugs. We have extensively studied
how the IL-36s and IL-1s promote inflammation and immunity during infections and chronic diseases. For
example, we showed how they regulate protective immunity through modulation of interferon responses and
recruit immune cells to the epidermis in the skin through induction of cytokines and their receptors. These
studies involved models of atopic dermatitis, psoriasis, and herpes simplex virus-1 and Staphylococcus aureus
infections. Pursuing new directions, we will here examine activation and inactivation mechanisms. Thus, this
project will improve our understanding of IL-36 functions. The gained insight will help guide clinical trials aimed
at neutralizing IL-36 and set the stage for targeted approaches involving small molecules.

Public health relevance
NARRATIVE IL-36 is involved in protective immunity against HSV and S. aureus but is also associated with chronic skin diseases such as psoriasis and atopic dermatitis. How IL-36 is activated and inactivated is poorly understood and will be examined in this study. Improved insight into these mechanisms may underpin development of targeted therapies for chronic inflammatory diseases.